Administrative Core

Modified Project Summary/Abstract Section
ADMINISTRATIVE CORE
The highly integrated nature of the University of Michigan O’Brien Kidney Translational Resource Center (MKTC) requires a robust and active Administrative Core, which will coordinate workflow, distribution of resources and operations assessment of the Biomedical Research Cores and Resource Development Core. The Core will continue to set goals and objectives for the Center’s operation and conduct ongoing review of the Center through consultation and survey of the core users, advice of NIDDK Advisory Committees and interactions with other institutional NIDDK centers, external O’Brien National resource Centers consortium through the Data Coordinating Center. In addition, the Administrative Core will organize, stimulate and evaluate interactions of the Center with our researchers to ensure that the Biomedical Research Cores and educational programs are providing optimal support. Maintaining a vibrant educational environment for kidney research, especially in T1 translational research, continues to be a major goal and the core will implement the effective Educational Enrichment Program including the Summer Students Research Program. The Administrative Core will oversee the resource expenditures of the MKTC and be responsible for the reporting to internal and external stakeholders and to the NIH. The Core, through the Core’s Working Group, will oversee all Cores, ensuring that expenditure of cost-share funds are properly allocated to support priority core services. The Core will also ensure that agreements between the administrations of entities who have agreed to co-funding will be properly executed and documented The Administration Core will maintain a Website for investigators and the public use to interact and to promote MKTC activities. The core will continue to support an Annual Educational Retreat for all research base investigators, to highlight translational research approaches, review research progress and obtain feedback on Center services. Throughout all these processes, the core will obtain quality assurance and improvement information from Research Base investigators.